MEGA-OCD: A Global Data-Driven Initiative to Discover Biosignatures of OCD

ABSTRACT
We launch the MEGA-OCD Initiative - the largest, most highly powered neuroimaging investigation of obsessive
compulsive disorder (OCD), drawing on diverse worldwide data to rigorously address pressing questions in OCD
with unprecedented statistical power. OCD is a leading cause of global disability, and a severe and debilitating
mental disorder. Symptoms start in childhood for about 50% of cases, and less than half of patients respond to
first line interventions, so most OCD patients have a chronic course. Multimodal neuroimaging can elucidate
circuitry and mechanisms underlying disease and treatment response, but studies have failed to address 3 major
barriers to discovery: 1) inadequate sample sizes with low statistical power, coupled with variation in unimodal
imaging methods, yielding a reproducibility crisis; 2) clinical heterogeneity (where brain correlates depend
on developmental and disease stage); and 3) poor representation of diverse populations. To address this
and NIH’s Call for Diversity, we create a highly-powered international study of unprecedented scale - the first
with the global inclusion and data harmonization expertise to identify factors robustly influencing disease course,
and genetic drivers of brain alterations. Drawing on 10 years’ experience coordinating international OCD studies,
we combine data from two worldwide OCD consortia: ENIGMA-OCD Consortium - where 43 sites in 18
countries actively participate with data from 3,583 OCD cases (668 children/2,915 adults) and 3,505 controls
(654 children/2,851 adults), and the Global-OCD Consortium - evaluating 268 deeply-phenotyped unmedicated
adults with OCD, 256 healthy controls, and 80 unaffected siblings across 5 continents (North and South America,
Africa, Asia, and Europe). Leveraging both samples and the expertise of these consortia, our Aims are: 1)
establish biosignatures of OCD by combining structural, diffusion, and resting state functional MRI, and
relate these ‘multi-layer’ signatures to age, developmental and disease stage, medication, and comorbidities.
We launch worldwide analyses of task-based fMRI (focusing on emotion, inhibitory control, executive function)
to yield novel functional insights into OCD; 2) use multimodal machine learning to fuse clinical and imaging
metrics to: discriminate OCD from health, identify OCD biotypes corresponding to clinical subtypes, and predict
treatment response; and 3) determine how OCD brain signatures relate to gene expression. A global
resource for OCD researchers, our novel MEGA-OCD Initiative will identify reproducible multi-modal
biosignatures of disease that incorporate diversity in developmental stage, clinical profiles (subtypes,
comorbidity, cognition) and culture. Robust brain-based signatures of OCD profiles and biotypes and
understanding neurogenetic risk for OCD will advance neurocircuit models of OCD, contribute to new treatment
targets, and provide a foundation for precision psychiatry. Leveraging diverse samples (ENIGMA-OCD: 43
sites/18 countries; Global-OCD: 5 sites/5 continents), our findings will have both local and global impact and be
relevant to populations around the globe.

Public health relevance
NARRATIVE Our proposed MEGA-OCD initiative – unique in its scale, statistical power, and diversity – unites experts worldwide in obsessive compulsive disorder (OCD), psychiatry, neuroimaging, and genomics to discover brain signatures of OCD that explain differences in clinical symptoms and course and that predict treatment response. The ultimate goal is to reveal the biological causes of OCD and to develop treatments that target these causes directly, with findings that are relevant for populations around the globe.